Project 1--Targeted therapies for pediatric low-grade astrocytoma (Eck/Wright/Haas)

Project Summary/Abstract Low-grade astrocytomas are the most common brain tumor in children.
Standard of care therapies have limited efficacy and treatment-related morbidity is significant. The broad
objective of our study plan is to develop potent, brain-penetrant, targeted therapeutics for pediatric low-grade
astrocytoma (PLGA). Towards this end, mutated, constitutively active forms of the BRAF protein kinase are
expressed in ~75% of all PLGAs and are attractive targets for drug development. A minor cohort of PLGAs
express V600E BRAF - a point mutation oncoprotein that is a frequent driver of malignant melanoma in adult
patients. More commonly, PLGAs express a truncation/fusion oncoprotein known as KIAA1549:BRAF. Small
molecule type 1 RAF inhibitors developed for adult melanoma have poor brain penetrance and are, moreover,
ineffective antagonists of KIAA1549:BRAF. Against this backdrop, we have three specific aims:
Aim 1 is to examine the clinical activity of TAK-580 in progressive, BRAF-mutant PLGAs. Under
auspices of this SPORE, we showed that TAK-580 (a clinical stage type 2 RAF inhibitor) has good brain
penetrance and targets both forms of the BRAF oncoprotein. A phase 0/I/II trial of TAK-580 in children with
BRAF mutant low-grade gliomas tumors has been initiated. Using clinical materials from the phase I and II
components of the trial we will establish the pharmacokinetics and pharmacodynamics of TAK-580 in children
relative to adult patients where the drug has been previously evaluated. In the Phase 0 component of this trial,
we will directly measure drug penetration into tumors.
Aim 2 is to define the impact of cellular and genetic modifiers on response of PLGAs to TAK-580. An
“inconvenient truth” in precision medicine is that target expression does not guarantee responsiveness to a
targeted therapeutic. For example, type 1 RAF antagonists are effective inhibitors of V600E BRAF in
melanoma but are ineffective on the same oncoprotein in colon cancers. Accordingly, as the TAK-580 clinical
trial goes forward, we will conduct a series of in vitro “avatar” trials on primary patient tumor cells grown in a
synthetic hydrogel system developed in collaboration with a bioengineering group at MIT. This system is
similar to “organoid” systems developed for other solid tumors.
Aim 3 is to develop second generation brain-penetrant drugs for BRAF-mutant PLGA with enhanced
selectivity for KIAA1549:BRAF. TAK-580 targets both forms of the BRAF oncoprotein, but WT BRAF is also
inhibited by the drug. Thus, TAK-580 is a “signal transduction inhibitor” but not a true targeted therapeutic.
Although signal transduction inhibitors can be highly efficacious cancer medicines (e.g., imatinib or
trastuzumab), a drug that is truly mutant-specific would be preferable for growing children. By far the most
common form of BRAF oncoproteins in PLGA is a truncation/fusion protein known as KIAA1549:BRAF. In this
aim, we take a mechanism-based approach to development of a drug that selectively targets KIAA1549:BRAF.

Public health relevance
Low-grade astrocytomas are the most common brain tumor in children. Current standard of care (surgery and chemotherapy) has limited efficacy and treatment-related morbidity is significant. The broad objective of this research is to develop potent, brain-penetrant, targeted therapies (a.k.a. “smart drugs”) for children with these tumors.